Molecular mechanisms and therapeutic principles of VISTA+ triple-negative breast cancers

Project Summary/Abstract
Triple-negative breast cancer (TNBC) is highly aggressive and uniformly lethal in the metastatic setting
despite recent approvals of immuno-therapeutics for this disease. Outcomes could potentially be improved by
closing gaps in our understanding of immunological control of TNBC. A subset of human TNBCs (6-20%) strongly
overexpress the immune receptor VISTA (V-domain immunoglobulin suppressor of T cell activation), which bears
close homology to the drug target PD-L1. Clinical trials in humans are now evaluating the safety and efficacy of
targeting VISTA’s extracellular domain for cancer. However, we lack a mechanistic understanding of how VISTA
signals to the interior of the cell. Preliminary data show that VISTA+ TNBCs have immunologically “cold” tumor
microenvironments and decreased proliferative index. These effects are controlled by both the extracellular and
intracellular domains of VISTA. By purifying proteins bound to the intracellular domain, we have established that
VISTA can recruit and sequester cytoplasmic clathrin-adaptor proteins, causing defects in plasma membrane
receptor endocytosis and trafficking. Consequently, important immunological and cancer growth receptors like
TLR4 and EGFR do not function effectively when VISTA is expressed. This leads to the hypothesis that VISTA’s
intracellular domain is a cell-intrinsic repressor of membrane receptor trafficking and that targeting both VISTA’s
extracellular and intracellular domains is critical to improve VISTA therapeutics.
This hypothesis will be tested in three specific aims: (1) To mechanistically dissect how VISTA blocks
receptor trafficking, we will characterize how proteins bind to VISTA’s intracellular domain; (2) Define the
mechanistic roles of VISTA’s intracellular domain binding partners in receptor trafficking and activity; and (3)
Evaluate therapeutic strategies for VISTA+ triple-negative breast cancers. These aims will be accomplished
through biochemical analysis of purified proteins and cell lines with engineered mutations to disrupt clathrin
adaptor binding to VISTA’s intracellular domain. Analysis will include the effects of VISTA in both tumor cells that
overexpress VISTA to model human TNBCs and immune cells that naturally express VISTA for normal
physiology. Combination regimens to explore the effects of blocking both extracellular and intracellular functions
of VISTA will be tested in immunocompetent mouse models of triple-negative breast cancer.
This work should address the need to develop novel immunomodulatory agents to improve outcomes for
TNBC. Although VISTA-targeted therapeutics are currently in clinical development, all current approaches
exclusively target VISTA’s extracellular domain. Our studies have discovered that VISTA’s intracellular domain
is a critical determinant of receptor function that we propose to extensively characterize to catalyze improved
VISTA-targeted therapies.

Public health relevance
Project Narrative Triple-negative breast cancer is highly aggressive and uniformly lethal in the metastatic setting, highlighting the need for improved immunological control strategies for this disease. This project seeks to evaluate how the intracellular domain of the immune checkpoint receptor VISTA functions in triple-negative breast cancer. This should lead to the development of novel immunotherapeutic strategies to target VISTA for breast cancer and possibly other malignancies.